Administrative Core

PROJECT SUMMARY The Administrative Core of the Washington University/University of Oklahoma/University of New Mexico Specialized Program of Research Excellence (SPORE) Route 66 Endometrial Cancer SPORE will provide executive oversight, advocacy review, and administrative support for three projects, two cores (Biospecimens, Metabolomics, and Pathology Core and the Biostatistics and Bioinformatics Core), and the Developmental Research and Career Enhancement Programs. The Administrative Core leaders will receive advice from an Endometrial Cancer Equity Group, Patient Advocates, an Internal Advisory Board, and an External Advisory Board. The first overall objective of the Administrative Core is to provide administrative support for the Route 66 Endometrial Cancer SPORE by overseeing all SPORE components, including subcontracts and per-case payment distribution; preparing annual progress reports to the National Cancer Institute; interacting with the Grants and Contracts Office at Washington University in St. Louis and with the Program Director and Chief of the Organ Systems Branch at the National Cancer Institute; and ensuring that all research with patient participants is ethical, respectful, safe, and mindful of patients' needs. The second overall objective is to provide organizational support for the Route 66 Endometrial Cancer SPORE by coordinating weekly PI meetings, monthly Steering Committee meetings, annual meetings of the External Advisory Board, and an annual retreat/Internal Advisory Board meeting; coordinating attendance at SPORE-related National Cancer Institute meetings; coordinating an annual endometrial SPORE research retreat with other Endometrial SPORE(s); ensuring effective communication and research and administrative collaboration between relevant personnel at the three institutions; and developing and maintaining a Route 66 Endometrial Cancer SPORE website and monthly electronic newsletter. The third objective is to provide scientific management for the Route 66 Endometrial Cancer SPORE by making decisions regarding whether to continue, discontinue, or replace full projects and whether to elevate Developmental Projects to the status of full projects; assisting investigators with preparing scholarly presentations, publications, regulatory documentation, and all other paperwork generated by the SPORE; and enhancing participation of underrepresented minorities in SPORE activities, both as researchers and as participants in clinical trials. The fourth objective is to provide administrative services for the clinical trials conducted within the Route 66 Endometrial Cancer SPORE by providing support and guidance for the proposed clinical trials and using the Washington University in St. Louis Institutional Review Board for single-site review. In accomplishing these objectives, the Administrative Core will help ensure that the Route 66 Endometrial Cancer SPORE achieves its mission of reducing the burden of endometrial cancer.